SARS-CoV-2-reactive tissue-resident memory T cells in healthy and cancer subjects

PROJECT SUMMARY
This multi-PI proposal titled “SARS-CoV-2-reactive
subjects” is written in response to ‘RFA-CA-20-039’ -
tissue-resident memory T cells in healthy and cancer
Research projects in SARS-CoV-2 Serological Sciences.
Recent studies have shown that antibody responses to SARS-CoV-2 infection decline rapidly over time, implying
a lack of durable protective humoral (B cell) immunity. Whether this is also true for cellular immunity (e.g., T
cells) is poorly understood. It is well established that CD8+ TRM cells are the first line of defense in viral infections
at mucosal/barrier sites. They are also known to protect hosts against homologous or heterologous re-infections.
Our group was the first to show that TRM cells are pivotal players in driving effective anti-tumor immune responses
in lung cancer, and that TRM cells are the primary cellular targets of anti-PD1 therapies. These key findings were
possible because of the ongoing collaboration between Dr. Vijayanand, Dr. Ay, and Dr. Ottensmeier (Multi-PI).
This team brings together experience in T cell immunology, single-cell genomics, bioinformatics, and cancer
immunology. Our Multi-PI team has recently performed the first and largest single-cell RNA-seq and TCR-seq
analysis of SARS-CoV-2-reactive CD8+ and CD4+ T cells (~300,000 single-cells) from COVID-19 patients. Here,
to understand TRM responses to SARS-CoV-2, we will capitalize on a cohort of cancer (n=100) and non-cancer
(n=100) patients, who will provide excess airway (nasal, oropharynx, larynx), lung and tumor tissue specimens
obtained during routine surgery. In AIM 1, we will define the properties of SARS-CoV-2 reactive TRM cells from
cancer and non-cancer patients with or without previous SARS-CoV-2 infection. We will perform combined
single-cell RNA-seq and TCR-seq analysis of CD8+ TRM cells in the airways (nasal, oropharynx), lung, and tumor
tissue. In parallel, by stimulating PBMCs with SARS-CoV-2 peptide pool, we will determine the transcriptomic
and TCR sequence of SARS-CoV-2 reactive T cells. We will utilize this TCR sequence information to define the
numbers and properties of SARS-CoV-2 reactive-TRM cells in mucosal and tumor tissues. Recent studies in non-
exposed individuals (pre-COVID-19 pandemic) indicate pre-existing, circulating CD8+ T cells, with human
coronavirus cross-reactivity. Here, we will measure the quantity and quality of pre-existing SARS-CoV-2 cross-
reactive TRM responses in subjects without clinical or serological evidence of previous SARS-CoV-2 infection. In
AIM 2, we will assess the impact of SARS-CoV-2 infection on anti-tumor and other anti-viral TRM responses. We
will stimulate matched PBMCs (as above) with peptide pools targeting (i) common respiratory RNA viruses
(influenza (FLU), RSV), (ii) persistent DNA viruses (CMV, EBV), and (iii) a tumor-driving virus (HPV) to define
the TCR sequence of the respective virus-specific and tumor(HPV)-specific CD8+ T cells; we will utilize the TCR
information to determine frequency and properties of other virus/tumor-reactive TRM cells in mucosal and tumor-
tissue cells.

Public health relevance
RELEVANCE – Parent Grant COVID-19 is one of the greatest threats to mankind and has caused substantial mortality, morbidity and huge economic losses. There seems to be no clear path as to when this pandemic will end, as vaccines and new therapeutics may take several months or years to come to fruition. Despite the importance of tissue-resident memory T cells in the control of viral infections and providing immunity against future infection, we do not know if SARS-CoV-2 infection generates TRM responses at the sites of infection. Here, we will employ cutting-edge single-cell RNA-seq assays to characterize properties of SARS-CoV-2 reactive TRM cells in airway/lung and tumor tissues from cancer and non-cancer patients with or without previous SARS-CoV-2 infection.